PHARMACOKINETIC AND TOLERENCE OF ORAL GANCICLOVIR IN HIV INFECTED CHILDREN

The purpose of this study is to determine the pharmacokinetics, maximum tolerate dos and long term safety of oral ganciclovir in HIV-infected infants, children and adolescents with CMV infection or quiescent CMV disease.